Combining Laboratory and Ecological Momentary Assessment-based Methods to Determine Age-related Differences in the Relationship Between Alcohol Use, Pain, and Inflammation

PROJECT ABSTRACT
Pain and problematic alcohol use have substantial public health consequences and co-occur at high rates.
Pain-related alcohol use is common and concerning; although alcohol use may provide short-term relief from
pain, it may also worsen pain and alcohol use consequences over time. Understanding the factors that underlie
whether physical pain leads to alcohol can inform intervention efforts that address both pain and problematic
alcohol use. This project will help understand (1) potential pathways from pain to alcohol use and (2) factors
that impact the pain-alcohol relationship over time. Specifically, this project combines laboratory-based pain
induction and ecological momentary assessment (EMA – i.e., daily text-message surveys) to investigate two
hypotheses of pain-related alcohol use. First, we hypothesize that pain increases negative affect (e.g., anxiety,
anger), which then leads to alcohol use (i.e., a mediation effect). Second, we hypothesize that pain-related
alcohol use is most prevalent among people with low capacity to modulate their experience of pain (i.e., pain
modulatory capacity) and high impulsivity (i.e., moderation effects). To test these hypotheses, we will recruit
225 community adults (aged 25-80). At a baseline laboratory appointment, we will assess individual differences
(e.g., negative emotionality, impulsivity), systemic inflammation (via circulating cytokines), and pain modulatory
capacity during laboratory pain induction. After baseline, participants will complete a 30-day EMA protocol
consisting of five daily assessments via smartphone app. Each smartphone survey will assess substance use,
pain, craving, and negative affect. Leveraging these data, we will first test whether the pain-alcohol relationship
is mediated by negative affect in daily life (Aim 1). We will also test whether the pain-alcohol relationship is
stronger among people with lower pain modulatory capacity and higher impulsivity (Aim 2). Finally, we propose
that pain-related alcohol use cannot be fully understood without considering biological age. Age is related to
increased pain and chronic pain conditions; decreased negative affect, impulsivity, and pain modulatory
capacity; and increased sensitivity to alcohol. Age is also associated with greater inflammation, and the two
have similar associations with key facets of pain and alcohol use. It is unclear whether inflammation and aging
are independent risk factors for pain and pain-related alcohol use. Thus, we will examine whether effects
tested in Aims 1 and 2 vary as a function of age, and whether age and inflammation independently affect pain-
related alcohol use (Aim 3). Findings across all aims will determine whether modifiable risk factors are
promising intervention targets and whether the relevance of these factors varies as a function of age or
inflammation.

Public health relevance
PROJECT NARRATIVE Pain and problematic alcohol use each cost hundreds of billions of dollars annually, are attributed to increased mortality, and co-occur at high rates. Evidence across the literature suggests important age-related differences in how pain is associated with alcohol use, but age has generally been overlooked with regard to pain-related alcohol use. By combining data from laboratory-based pain-induction tasks and brief smartphone- based surveys, this project will examine mechanisms and age-related differences underlying pain-related alcohol use.